Aptamer-based LYTACs to screen for critical determinants of lysosomal degradation

PROJECT ABSTRACT Extracellular and transmembrane proteins are central pathological components in cancer, aging-related disorders, and autoimmune disease. These proteins can be degraded using lysosome targeting chimeras (LYTACs), antibodies conjugated to polymeric chemical moieties engaging the cation-independent mannose-6- phosphate receptor (CI-M6PR). As these molecules require careful chemical synthesis, we will produce alternate LYTACs in high throughput using aptamers targeting CI-M6PR linked to nanobodies via enzymatic autoconjugation. This method will help elucidate optimal LYTAC binding affinities to CI-M6PR. We will further use enzymatic autoconjugation to produce aptamer-LYTACs within bacterial cells in a genetically-encoded fashion, enabling future work to define the LYTACable proteome.

Public health relevance
PROJECT NARRATIVE Our lab has previously made a technology called LYTAC to degrade harmful proteins that cause disease. The project proposed here will explore other versions of LYTACs that would help us understand how to increase their potency in future therapies. This will also be a new method to degrade disease-related proteins and to expand access of LYTACs to more researchers.